Understanding the mechanism of H3K9 HMT mediated suppression of melanoma

PROJECT SUMMARY Alterations in the epigenome have been associated with changes in cellular identity and have emerged as important drivers in human cancer. In melanoma, we have shown that overexpression of SETDB1 and SUV39H1, two histone 3 lysine 9 methyltransferases (H3K9 HMTs), accelerate melanoma formation in zebrafish and are also amplified in human cases. Recently, our lab has used the histone 3 lysine-to-methionine mutation at K9 (H3.3K9M) to interrogate the consequences of H3K9 HMT loss of function. Remarkably, we find that expression of H3.3K9M suppresses tumor onset. Because histone methylation is known to play a critical role in proper maintenance of cellular identity, we hypothesize that loss of H3K9 HMT activity suppresses melanoma through inhibition of the progenitor phenotype, which has been shown to promote melanomagenesis. We propose using both zebrafish and human melanoma cell lines to identify the mechanisms through which loss of H3K9 HMT activity suppresses melanoma formation.

Public health relevance
PROJECT NARRATIVE Melanoma results in the majority of skin-cancer related deaths, and dismal survival rates for metastatic patients highlight the necessity of developing novel therapies. In our zebrafish melanoma model, we have shown that changes in H3K9 methyltransferase activity alter the rate of melanoma formation. In this research proposal we will use zebrafish and human melanoma cells to characterize H3K9 methyltransferase function in melanoma.